Administrative Core

The Administrative Core is led by the U54’s Principal Investigators, Ernest Martinez, Ph.D. (PI, University of California, Riverside [UCR]) and Victoria Seewaldt, M.D. (PI, City of Hope Comprehensive Cancer Center [CoHCCC]). The overall mission of the Administrative Core is to facilitate the UCR–CoHCCC U54 partnership by providing high-quality scientific leadership, administrative support, and fiscal management. The Administrative Core supports U54 planning, priority-setting, and implementation. The Core will support the ability of the External Advisory Board (EAB), Internal Advisory Board (IAB), and Community Advisory Board (CAB) to guide and provide advice and oversight of our U54. Together, we will work with the Planning and Evaluation Core (PEC) and serve as the U54’s oversight body. The PEC, IAB, and EAB will perform yearly review of Full and Pilot Projects and Cores. The CAB will evaluate Projects and Cores – particularly our Community Outreach Core – and assess our ability to mentor and promote the careers of early-stage investigators. The EAB, IAB, and CAB will meet jointly with U54 Project and Core leaders to assess overall progress and ability to impact cancer priorities in drug development and clinical trials. Aim 1 will provide U54 liaison with the National Cancer Institute. Aim 2 will provide logistical support for the IAB, EAB, and CAB. Aim 3 will advise, coordinate, and monitor progress of the U54.